The LungMAP Data Coordination Center for Next Gen Systems Biology of Respiration

PROJECT SUMMARY
The LungMAP 2 initiative will create detailed molecular maps of the neonatal, pediatric and early adult human
lung to enable improved understanding of functionally and anatomically defined cell types. The Data
Coordination Center (DCC) will serve as the nexus of LungMAP 2's collective knowledge and activities. The
DCC is responsible for data collation, re-analysis, and integration; secondary annotation tracking; developing
tools to facilitate collection, sharing and data dissemination; operating a web resource for data, expertise, and
collaboration; and coordinating activities across the Research Centers (RCs) and Human Tissue Core. The
DCC will also facilitate literacy for investigator use of developed tools and best practices for analysis, data
provenance and metadata annotation, and engage the larger research community. To host the DCC, we have
assembled a multidisciplinary team with data network leadership, along with leaders in single-cell genomics,
image analysis, functional inference, and data re-utilization. The DCC leverages unique expertise at CCHMC,
UCSC, and the Broad Institute to interoperate pulmonary-oriented single-cell and high-resolution imaging data
with other atlas programs. We also include world-renowned pulmonary researchers into our leadership team to
ensure the data and knowledge we provide to the research community has the greatest scientific impact.
Collectively, we propose to accelerate the LungMAP scientific agenda by coordinating efforts across funded
Centers, the NIH, and the pulmonary research community; cross-validate, annotate, deposit and link
Consortium datasets and metadata that encompass molecular -omics, imaging, and associated structural
models; and enable sharing of data, results, and models within LungMAP and the research community.
The datasets and results derived from the RCs are expected to yield significant new insights into lung
maturation, intra-donor variation and disease pathogenesis. To ensure the underlying data produced by the
RCs is findable, accessible, interoperable and re-usable (FAIR), the DCC will work closely with the RCs to
establish and share best practices, coordinate metadata annotation, ensure studies are sufficiently powered,
assist with the deposition of harmonized data of high integrity to secure repositories, and provide data access
and standardized analysis workflows. Through the continued development of structured ontologies and
metadata frameworks, RC-derived datasets will be annotated and harmonized using emerging best practices.
The DCC will support the ingestion and validation of data and analysis from new technologies as they emerge.
We will support the generation of centralized, cloud-enabled data processing workflows that are compatible
with external initiatives such as HubMAP, BRAIN, and the HCA. We expect that providing these functions in a
web-enabled LungMAP Commons will promote interaction across many stakeholders. This will position the
LungMAP DCC to become a hub for data sharing, data integration, collaboration and hypothesis generation for
investigators studying lung development and disease.

Public health relevance
PROJECT NARRATIVE: The abilities to obtain high-resolution 3D tissue images and single-cell molecular profiles have opened the door for new opportunities to understand the human lung across space, time, and disease state. Our proposed Data Coordination Center will provide vital services to the LungMAP research community by promoting collaboration, educating trainees, harmonizing and integrating data and delivering these data in an organized manner to the larger research community. This work is expected to accelerate collaborative science within the second phase of the LungMAP that results in crucial new insights into lung development.